Oxysterol-Binding protein like 7 in chronic kidney disease

Project Summary
Derangement of metabolic pathways involved in cellular lipid metabolism1 and ER stress2 have been shown
to contribute to the pathogenesis of chronic kidney disease (CKD). We3-6 and others7 demonstrated that ATP-
binding cassette transporter A1 (ABCA1) deficiency contributes to podocyte injury and disease progression of
glomerular diseases of metabolic and non-metabolic origin. While ABCA1 deficiency is insufficient to cause
podocyte injury, in vitro or in vivo, and proteinuria despite causing impaired cholesterol efflux and mitochondrial
dysfunction5, overexpression of ABCA1 or pharmacological induction of ABCA1 (ABCA1i)5 was sufficient to
rescue glomerular injury in proteinuric mice. Proximity labeling followed by immunoprecipitation of transfected
potential targets led to identifying oxysterol binding to oxysterol-binding protein (OSBP) like 7 (OSBPL7) as the
target of ABCA1i8. OSBPL7 is a member of a group of lipid-binding proteins involved in the movement of lipids
between membranes8. OSBPs play a role in initiating autophagy9, cholesterol transfer from the endoplasmic
reticulum (ER) to the Golgi, cholesterol efflux, and regulating ABCA1 expression10. However, if OSBPL7 is
expressed in the kidney and if it is involved in regulating ABCA1-mediated cholesterol efflux or in the
preservation of ER function in the podocyte has not been explored. The proposed research will
investigate the function of OSBPL7 in podocytes. Based on my preliminary data, I hypothesize that
OSBPL7 deficiency causes ABCA1-dependent impairment of cholesterol efflux and ABCA1-
independent ER stress, thus linking OSBPL7 to podocyte injury and CKD progression. I propose the
following specific aims using in vitro and in vivo approaches: (SA1) In vitro, determine the role of OSBPL7 in
modulating ABCA1-dependent functions in podocytes. (SA2) In vitro, determine the mechanism by which
OSBPL7 deficiency contributes to ER stress independent of ABCA1. (SA3) In vivo, determine if restoring renal
OSBPL7 levels is sufficient to preserve renal function in col4a3 depleted zebrafish. I have created a
comprehensive career development plan supported by my mentor and co-mentor to ensure my
progress and success in this research proposal and facilitate my transition to an independent research
career focused on lipid metabolism in association with glomerular disease. This plan includes (1) regular
meetings with my mentor, co-mentors, and advisory committee, to provide research and career guidance, (2)
research and career development seminars, learning new research methodologies, and (3) activities for career
growth, including mentoring, publication, presentation, and application for independent research funding. My
training will be conducted in an unparalleled academic environment at the University of Miami, Miller School of
Medicine, which provides dedicated career development programs and necessary research support and
supplies through my mentor, co-mentors, and institutional core services. This research and career
development proposal is a product of my ambition and capacity to transition to an independent
research career.

Public health relevance
Project Narrative Chronic kidney disease affects around 14% of the global population. The number of affected individuals is expected to continue to rise. We show that deficiency of a protein named oxysterol binding like protein-7 affects the viability of podocytes, a critical cellular constituent of the kidney filtration barrier. The findings derived from this application will offer novel insights into the metabolic pathways regulated by OSBPL7 in podocytes and other cell types.